Effects of microbial exposure on TB pathogenesis

Tuberculosis (TB) is the leading cause of death by a bacterial disease worldwide. Differences in lung
microenvironments, including the granuloma, influence the support and suppression of Mycobacterium
tuberculosis (Mtb). While factors that impact microenvironment specific immune responses and Mtb sterility in
the lung are incompletely understood, recent studies have shown that the microbiome takes an active role in
shaping the immune response. Both lung and gut microbiomes have been shown to influence disease outcome
in influenza, cystic fibrosis, asthma, cancer, and COPD. The dominant animal model used in TB is the mouse.
While laboratory breeding of mice in specific pathogen free (SPF) and hygienic conditions has increased
reproducibility, it has also removed much of the microbial exposure experienced by free-living organisms. Daily
encounters with microbes help sculpt the immune system for a robust response against new pathogens.
Unfortunately, the immune system of SPF mice lacks effector differentiated CD8+ memory T cells, which are
critical cell types for an immediate response to infection. It is unknown how prior experience to microbes
impacts TB progression. This proposal leverages a novel mouse model (‘dirty’ mouse model) that creates
multiple exposures to diverse microbes to shape the immune response in SPF mice. Microbially experienced
pet store mice will be housed with C3HeB/FeJ SPF mice; thereby, transferring both commensal and
pathogenic microbes between animals. C3HeB/FeJ mouse strain is selected as it forms multiple types of TB
granulomas similar to human TB. The overall goal of this project is to determine how prior diverse microbial
experiences influence the course of TB infection (‘dirty’ vs. SPF mice). The central hypothesis is that the lung
and gut microbiomes of dirty C3HeB/FeJ mice will maintain equilibrium in the face of infection and shape the
immune system to resist and control Mtb as compared to SPF mice. This proposal will define changes to 1)
lung and gut microbiota diversity, 2) locations and interactions of microbiota inside granulomas and lungs, 3)
innate and adaptive immune cell populations, and 4) IL-23 pathway, a critical host response in the control of
TB, in dirty and SPF mice. The dirty mouse model will serve as a complement to existing small animal models
of TB to reveal new biomarkers and host-directed treatments to TB that are influenced upon prior microbial
experience. The outlined studies push the boundaries of our current understanding of TB pathogenesis and
may ultimately show TB as a disease that is defined by intimate interactions between the pathogen, host, and
microbiota.

Public health relevance
Tuberculosis (TB) is responsible for an estimated 1.3 million deaths worldwide. Recent studies have shown that the lung and gut microbiomes shape local immune responses and influence disease outcome. The overall goal of this project is to determine how prior diverse microbial experiences influence the course of TB infection.